Integrative predictive medicine to identify disease causes, develop cures, and optimize patient care

Project Summary/Abstract
The Laboratory for Pathology Dynamics was founded on the principle that pathology is multifactorial, multi-
scalar, and driven by complex interacting dynamics. This proposal builds and applies new predictive medicine
technology that enables multifactorial, multi-scalar data integration to identify disease causes, develop cures,
and optimize patient care. Key knowledge gaps addressed include: 1.) integration of siloed relationships for
interactive literature-based discovery across 33+ million journal articles, including the development of a
comprehensive biomedical knowledge graph software called SemBioSys; 2) high-throughput automated meta-
analysis to quantify effect size across cohorts and scales using a combination of newly developed deep
learning, active learning, interactive weak supervision and human in the loop artificial intelligence (AI)
algorithms into a single interactive software; 3) de novo multimodal machine learning algorithms to investigate
multifactorial, multi-scalar disease dynamics; 4) human in the loop methods for enhancing AI accuracy, utility,
and interpretability, which leverages our large test bed of diverse high school and undergraduate curators
acting as subject matter experts. The developed technology will be applied to a bevy of multifactorial diseases
in collaboration with clinicians and experimentalists: neurological diseases (Alzheimer’s Disease, Amyotrophic
Lateral Sclerosis, Parkinson’s Disease), cancers (adult and pediatric acute and chronic leukemias and solid
tumor cancers), cardiovascular disease, and infectious disease. The significance of this project is integrative
technology to identify and rank novel disease mechanisms, discover and prioritize novel and repurposed
drugs, and to optimally stratify patients for fair and equitable clinical trials that minimize health outcome
disparities. The innovation includes new integrative biomedical natural language processing (NLP), multimodal
machine learning, and dynamic disease modeling and event sequencing algorithms that can be generalized to
all of medicine.

Public health relevance
Project Narrative This proposal seeks to build and apply new predictive medicine technology that enables multifactorial, multi- scalar data integration to identify disease causes, develop cures, and optimize patient care for all of general medicine.